NVEADRC Outreach, Recruitment, and Engagement Core (OREC)

NVEADRC OUTREACH, RECRUITMENT ENGAGEMENT CORE
SUMMARY
Our Nevada Exploratory Alzheimer’s Disease Research Center (NVEADRC) aims at reducing dementia care
disparities in rural communities and developing an innovative research program to investigate the possible
differences in disease trajectory of rural patients suffering Alzheimer’s disease (AD) and Alzheimer’s disease
related dementia (ADRD). Prior research has identified two major issues with regards to dementia care in rural
populations. First is a lack of skills by rural medical professionals to diagnose and manage dementia due to both a
lack of proper medical training, and a lack of adherence to practice guidelines for the diagnosis and management
of AD/ADRD. Because the first providers to diagnose and care for dementia in rural areas are primary care
providers (PCP), there is an urgent necessity to provide improved and continuous education in AD/ADRD to answer
PCPs’ older patients needs with regards to the detection and/or management of dementia. The second issue is a
general lack of knowledge about dementia and other neurodegenerative disorders (NDD) in rural populations. In
addition, because of the low population density, lack of infrastructures, weather conditions, and scarcity of
community activities, there is a higher level of social isolation in rural communities, which is known to be a risk
factor for dementia in older individuals. To address this complex social topic of dementia care in rural populations
and to make our ambitious project successful in the long-term, we have decided to foster a robust Outreach,
Recruitment Engagement Core (OREC) from the genesis of the NVEADRC. OREC will comprise investigators
from both the Cleveland Clinic Lou Ruvo Center for Brain Health, Las Vegas (LRCBH) and University of Nevada,
Las Vegas (UNLV). There are three main goals pursued by the OREC. In Aim 1, OREC will use its technology and
network of medical collaborators to educate rural medical professionals on dementia. In Aim 2, OREC intends to
increase NDD awareness in rural communities by leveraging statewide initiatives, community action groups,
community/tribe/religious leadership, and associations (e.g. Alzheimer’s Association) to improve the knowledge of
the general population on dementia. This will be accomplished via a combination of seminars, lectures, websites,
and notebooks written in layman terms targeting rural populations. OREC will also use these communication
vessels to invite individuals to participate in our rural research cohort. In Aim 3, OREC will utilize its didactic
experience to supervise the mentoring of junior scientists who have an interest in investigating rural dementia and
healthcare disparities. These junior investigators will attend at least one rural community outreach event offered by
OREC to become aware of the interests, concerns, and needs of rural populations in term of dementia care. We
anticipate that our outreach efforts targeting rural communities will reduce stigma and enable dementia patients to
fully engage within their communities, while also connecting families living with dementia to information, support,
and services as early as possible, thus, improving quality of life.